Neural circuit mechanisms for a mirror-induced self-directed behavior

PROJECT SUMMARY
The ability to remember one's own features and monitor the current states is a fundamental for self-
recognition. To experimentally demonstrate the visual self-recognition, a mirror-induced visual self-recognition
(MSR) test was developed for non-human primates, which requires animals to remember visual features of
their own heads as a reference memory and recognize the current status via a mirror reflection. Human brain
imaging and electrophysiological studies have suggested several brain regions potentially important for visual
self-recognition. Especially, prefrontal cortex (PFC), posterior parietal cortex (PPC) and hippocampus (HPC)
are currently considered to be crucial for visual self-recognition. However, how neurons, circuits and inter-
regional network activity in the brain accomplish this remarkable function remains unknown, due to a limited
availability of experimental animal models. Although the ability of MSR was initially reported in only few
species, by modifying the experimental conditions to adjust to their nature, birds, fishes and rhesus macaques
were also able to show MSR, suggesting that MSR may present in many more species than previously
thought. Our goal is to examine the neural circuit mechanisms for MSR using a mouse model, focusing on
how mice remember visual features of the self and recognize the current status via a mirror reflection.
Our recent studies indicate that mice display mark-directed head-grooming to remove ink stains on
their heads only when a mirror is visibly available. This mark-directed behavior requires long-term mirror
habituation and social experience in the home cage. Our preliminary study with whole-brain neural activity
mapping using immediate early gene expression revealed that both the medial PFC (mPFC) and HPC are
activated during MSR in mice, suggesting that these brain regions involved in MSR are preserved across
species. We found that chemogenetic inhibitions of ventral HPC impair MSR. Specifically, a subset of ventral
hippocampal CA1 (vCA1) neurons is highly reactivated during exposure to a mirror, but not to other
conspecifics, and is crucial for MSR in mice. We refer to these as self-responding neurons. Based on our
preliminary data, previous human studies, and anatomical connections, our central hypothesis is that
hippocampal-prefrontal cortical circuits may be crucial for MSR. In particular, we posit the conceptual
framework that the visual self-image may be developed and stored in a subset of vCA1 neurons through
social experiences and mirror habituation, while mPFC may facilitate visual self-monitoring for MSR by
integrating the visual self-image from vCA1. To test these hypotheses, we will examine i) the roles of vHPC
and mPFC neural activity on MSR (Aim 1), ii) the roles of self-responding vCA1 neurons on MSR (Aim 2) and
iii) the roles of vCA1→mPFC pathway on MSR (Aim 3). We believe our proposed study is highly adventurous,
because it will provide a first demonstration of the detailed functional map of the hippocampal-prefrontal
cortical circuit that controls visual self-recognition.

Public health relevance
PROJECT NARRATIVE The ability to remember one's features and monitor current states is fundamental for self-recognition, yet the mechanisms governing how neurons, circuits, and inter-regional functional connectivity in the brain accomplish visual self-recognition remain unknown. By taking advantage of a mouse model, our proposed study aims to demonstrate the most detailed functional map of the hippocampal-prefrontal cortical circuits that control visual self-recognition.